Evolution and Latency of T-Tropic and M-Tropic HIV in People Infected with Subtype C

PROJECT ABSTRACT
Studies of people infected with HIV-1 from the subtype B lineage of virus have led to important insights on the
nature of the transmitted virus, early dispersal of the virus throughout the body, evolution of macrophage-tropic
virus late in the course of infection (especially in the CNS), and the phenomenon of latency (especially within
CD4+ T cells in the lymphoid system). However, these questions have been studied to only a limited extent in
people who have HIV-1 infections from the most common subtype, i.e. subtype C. In addition, the nature of viral
evolution within the CNS to form macrophage-tropic HIV-1, and the cell types that may contribute to a latent
reservoir within the CNS are poorly understood. The proposed work is built on the availability of a unique autopsy
tissue repository and a novel model cell culture system to explore these questions in the context of infection with
HIV-1 from subtype C lineage. The tissue repository for autopsy tissue from recently deceased individuals
infected with subtype C lineage has been established at the University of the Witwatersrand by Drs.
Papathanasopoulos and Wagner, and additional autopsy tissue samples are being collected for this repository.
In addition, Drs. Symons and Nijhuis have access to viable human brain tissue (from non-HIV donors) collected
during rapid autopsy which they have used to develop in vitro infection models for primary microglia and single
nuclei analysis. These tools, coupled with Drs. Swanstrom and Joseph expertise in viral evolution and genetics
are the basis of an international collaboration that will bring new insights into the nature of HIV-1 latency in the
brain and do so in the setting of the most common lineage of HIV-1 infection. With these aims we will: i) determine
the frequency that macrophage-tropic virus evolves within the immune-privileged confines of the CNS; ii) identify
which cell types within the CNS are expressing virus; iii) determine how early macrophage-tropic virus evolve in
the disease course; iv) compare long-lived viral DNA populations in the CNS to those in lymphoid tissue to
determine if there are compartmentalized reservoirs; v) sort nuclei based on cell origin to determine which CNS
cell types contain long-lived viral DNA; vi) use sorted nuclei to search for virus-expressing cells; vii) use M-tropic
subtype C viral clones to establish a validated model of viral latency in primary microglia cells. Finally, we will
explore these questions in samples collected from both men and women to examine if sex is a significant
biological determinant of the nature of the CNS reservoir.

Public health relevance
PROJECT NARRATIVE HIV-1 normally grows in CD4+ T cells but under certain circumstances it can evolve to grow in myeloid cells within the central nervous system (called macrophage tropism). The appearance of macrophage-tropic virus in the CNS and the potential of these variants to form a myeloid reservoir have been described for subtype B virus, but the frequency and timing with which this happens is unknown, and the entire phenomenon has not been studied in the subtype C epidemic, especially in Sub-Saharan Africa. We will study these questions using brain autopsy material from men and women who were infected with the subtype C lineage of HIV-1.